Development of Temporal Fine structure

PROJECT SUMMARY
The broad goal of the proposed research program is to advance our understanding of sound localization. Even
when a person has normal hearing, speech perception and learning in noisy reverberant environments may
still be compromised due to persistently impaired binaural hearing capabilities. In more profound cases of
deafness, bilateral cochlear implant users typically experience poor discrimination of interaural time differences
(ITDs), potentially because of early deprivation. This proposal uses an avian model to advance our
understanding of binaural development. We have developed this preparation to determine if/when there is a
developmental window in which inputs from each ear are synchronized, in order for sensitivity to ITDs to
develop. Sensitivity to binaural signals first appears in the brainstem and relies on sub-millisecond precision to
detect ITDs. How such extreme precision comes about during development is not fully understood, and these
birds provide a well understood model for measurement of precisely timed binaural signals. Our knowledge of
this ITD circuit is detailed enough to test the following hypotheses about the physiology and development of
sound localization circuits. In the broader context, understanding the mechanisms of sound localization should
reveal common computational solutions to guide advances in hearing aid and cochlear implant design. The
three overlapping areas to be investigated in this project are:
1. Determine if the representation of ITDs is plastic during development.
Detection of ITDs depends on precise coding of delay, with current research on how ITDs change with head
growth. We will use a unilateral conductive hearing loss (CHL) model, in which one ear canal is plugged
around the onset of hearing, to induce experience dependent plasticity during the period of head growth.
These experiments should allow us to determine if maps of ITD are modified by early experience. In Aim 1.2
we will focus on myelin plasticity as a potential mechanism for modification.
2. Address mechanisms underlying the emergence of temporal precision.
If delays can be modified by altered experience, it is likely that normal ITD coding also shows developmental
refinement. Delay lines encode time with sub-millisecond accuracy. To shed light on the mechanisms
underlying ITD map formation, we will combine recordings of the extracellular field potential with intracellular
recording from delay line axons to measure the development of ITD coding in the first 2 months posthatch.
3. The role of inhibition in the development of ITD coding.
Given the importance of inhibition in regulating auditory brainstem activity, we will examine the nature of the
inhibitory input to NL and cochlear nuclei. We will use the unilateral CHL model to induce experience
dependent plasticity in map of ITD, and test the competing hypothesis to Aim 1.2, that changes in delay are
correlated with changes in inhibition.

Public health relevance
NARRATIVE The noteworthy similarities and the differences between sound location processing in birds and mammals show there are many ways of localizing sounds and separating sources from background noise; these different strategies can inspire the development of new technologies such as cochlear implants. Current binaural implants work independently, so that the timing of pulses is not synchronized or coordinated between the ears, and much of the fine temporal structure required for effective ITD processing is not preserved. In the broader context, understanding the development of temporal fine structure should reveal common constraints on the development of binaural hearing to guide technological advances.